A Nursing Program for Advancing Training in Health and Social Determinants (N-PATHS)

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The Nursing Program for Advancing Training in Health and Social Determinants (NPATHS) is a comprehensive research training initiative for nurse scientists consisting of three core components: 1) in-person intensive, 2) monthly learning modules (asynchronous) and webinars (synchronous), and 3) mentored research experiences. The program is designed to support early-career nurse scientists and allied healthcare professionals in acquiring the knowledge and skills needed to conduct and disseminate research about important determinates of health to improve health outcomes for all patients. The program goals are to: 1) Enhance participant understanding of determinates of health frameworks and concepts; 2) Strengthen their capacity to apply these concepts in the design, analysis, implementation, and dissemination of research; and 3) Expand the volume and rigor of nurse-led research focused on health outcomes research. The 10-month program begins with an in-person intensive that fosters collaborative learning and relationship-building for research skill development. Participants will also participate in monthly webinars (synchronous) and have access to online, self-paced modules (asynchronous) to support applied learning and research skill development. Participants will also engage in one-on-one mentorship to facilitate mentored research experiences. The program is open to those with a nursing background and allied health professionals. Curriculum development is planned will be reviewed by an interdisciplinary advisory committee. The planned activities include curriculum development, and recruitment in Year 1, followed by implementation and dissemination activities in Years 2 and 3.

Public health relevance
The Nursing Program for Advancing Training in Health and Social Determinants (NPATHS) program is a comprehensive research training initiative for nurse scientists. The program seeks to cultivate foundational knowledge, enhance methodological rigor, and expand policy-relevant evidence about important determinates of health to improve health outcomes for all patients. NPATHS delivers an immersive curriculum, including networking events, didactic sessions, interactive webinars, community-based learning, and mentorship to build research expertise that prioritizes improvements in population health.